Immune-driven Airway Epithelial Dysfunction in Muco-obstructive Asthma

OVERALL SUMMARY
This proposal seeks continued support for the UCSF Asthma and Allergic Diseases Cooperative Research
Center’s longstanding and productive efforts to understand how type 2 immune responses in the airway act on
epithelial cells to produce muco-obstructive pathology, a central feature of severe asthma and a major contributor
to fatality from this disease. Our Center has made major contributions to identifying type 2 high asthma as the
major asthma endotype, demonstrating that the type 2 cytokine IL-13 acts directly on airway epithelial cells to
induce pathological changes in mucus, and showing that mucus plugging is a persistent feature of asthma that
is associated with type 2 responses and with increased asthma severity. The overall objective of this proposal is
to understand molecular mechanisms that account for alterations in secretory cell and mucus function that are
important in severe asthma. The overarching hypothesis that serves as the focus of this renewal is that local
type 2 immune responses induce IL-13-mediated changes in epithelial gene expression and that these changes,
which involve several novel molecular mechanisms not previously explored, alter differentiation of secretory cells
and production and secretion of mucins, leading to mucus plugging and airway obstruction. The proposal
includes two highly related projects, each of which focuses on molecules and pathways that have previously
unknown roles in secretory cell biology and mucus dysfunction. Project 1 will determine the roles of the
tetraspanin TSPAN8, which we recently found to be required for stimulated release of MUC5AC, the major
component of mucus plugs, and investigate the contributions of cysteine proteases and cystatin inhibitors
implicated in our preliminary studies of mucociliary clearance in IL-13-stimulated primary human bronchial
epithelial cells (HBECs). In addition, project 1 will directly assess the relationships between type 2 immune
responses, epithelial alterations, and mucus plugging by analyzing lung tissue and HBECs from individuals with
asthma and controls. Project 2 focuses on understanding new findings showing key roles for airway epithelial
miRNAs in the miR-141/200 family and particular portions of the ER stress response in secretory cell
differentiation, pathologic mucus production, and mucus plugging in asthma. Every aim of both projects depends
upon a Clinical Subject and Biospecimen Processing and Analysis Core that will study banked lung specimens
(for detailed molecular studies of mucus plugs, including from fatal asthma), conduct a new bronchoscopy-based
study to obtain freshly isolated cells, provide banked human bronchial epithelial cells, and store, analyze, and
disseminate data. The Administrative Core will coordinate our Center and our interactions with other AADCRCs
and NIAID. The proposed studies will provide new mechanistic insights that are highly relevant to the
pathogenesis of severe asthma and may lead to novel therapeutic targets that address unmet needs.

Public health relevance
PROGRAM NARRATIVE Our Center is studying how immune responses in the lung result in production of excessive and abnormal mucus that plugs the airways and causes severe asthma. These studies will uncover new knowledge about mechanisms of asthma and help to pave the way for novel treatment approaches for this disease.